Fourth Advances in Pediatric Retina International Meeting

Abstract
This proposal seeks funding to support selected students and junior faculty to attend and present at the fourth
Advances in Pediatric Retina course international meeting to be held September 7-9, 2023. Pediatric retina
conditions are numerous but rare, so little is understood about their causes and management. Additional study
after retina fellowship training is necessary for retina specialists who wish to successfully manage pediatric
retinal conditions, because a two-year fellowship is not long enough to afford sufficient educational
opportunities that include management of a pathophysiologic spectrum of each disease. We request support
for students of pediatric retina, who have interest in pursuing or continuing the pursuit of diagnosing and
treating pediatric retina conditions. Besides support to attend the meeting, the students will have opportunities
to present their own clinical, translational or basic research in pediatric retina conditions and present in rapid-
fire fashion to the assembled audience of speakers and participants and then spend more time in networking
and building collaborations during a poster session. In addition to clinical expertise from international experts,
there will also be keynote lectures by translational scientists in basic, translational and clinical research to
explore new thinking of pathophysiology and treatment through lecture, panel discussions and presentations.
The objectives of this meeting are: 1. To bring together clinician/surgeons worldwide with expertise and interest
in a wide range of the most common and difficult public health concerns (i.e., involving pediatric retina) to
explore better management, treatments and cures, methods to optimize vision in developing children, and
disseminate knowledge; 2. To engage an international audience to address different manifestations of more
common pediatric retinal conditions in order to understand reasons and address barriers and incentives for
optimal treatments; 3. To incorporate basic, clinical and translational research to foster collaborations and test
hypotheses of pathophysiology and treatment of diseases; 4. To enrich diversity among students and junior
faculty and broadly disseminate knowledge about the diagnosis and management of pediatric retina conditions,
enhancing teamwork and networking to advance knowledge for future pediatric retina specialists. This fourth
Advances in Pediatric Retina course and international meeting will bring together pediatric retina specialists,
pediatric ophthalmologists and translational scientists to educate future and current pediatric retina specialists
to expand and improve our understanding and treatment of pediatric retina conditions.

Public health relevance
Narrative The Advances in Pediatric Retina meeting will bring together clinicians/surgeons with expertise in pediatric retina, pediatric ophthalmology, and clinical, translational and basic research to improve on the management of the conditions that threaten vision in infants and children. Key topics include retinopathy of prematurity, Coats’ Disease, inherited retinal diseases, surgery, and imaging. This meeting will enrich for diversity and include junior faculty in design to build leaders in pediatric retina for the future, introducing them into the pediatric retina network that will continue to provide venues for the expanding knowledge in pediatric retina as technology and science evolve.